Studies of Herpes Simplex Virus Glycoproteins

Program Director/Prindpai Investigator (Last, First, Middle): Cohen, Gary H. SENIOR/

Public health relevance
RELEVANCE (See instructions): Infections caused by herpes simplex viruses remain major health problems in the U.S. The genital form, HSV2 facilitates spread of HIV-AIDS. An effective vaccine against HSV2 is urgently needed. HSV uses 4 proteins, gB, gD and a gH/gL complex to invade cells. We will study how they work together and how the host responds with the long term goal of making effective vaccines and new therapeutics.